SCISIPBIO: Training Leaders - Professional Development, Mental Health, Mentoring

ABSTRACT:
The overall goal of this proposal is to examine the role of three critical components of graduate
training in determining successful outcomes. We hypothesize that important factors which
impact career outcomes and job satisfaction include participation in: a) professional
development (PD), b) mental health and wellness of trainees, and c) mentor-mentee match. We
will also measure and account for the potential explanatory effects of existing individual factors
including intersectional identities (underrepresented status in the sciences; e.g., race, gender,
LGBTQIA, first generation). Collectively, this evidence-based evaluation will be critical as
institutions decide how to focus limited resources to improve the training environment and
effectively train the biomedical workforce and future scientific leaders. The three specific aims
encompass the following: Determine the impact of professional development training on career
outcomes (AIM 1); Measure the impact of professional development participation and
engagement on trainee mental health (AIM 2); and determine the impact of mentor-mentee
match on scientific leadership career outcomes (AIM 3). In addition, this supplement will support
the professional development of an early career investigator by transitioning research areas of
expertise to include higher education research methods and experience. To enable a shift to
independent research in this area, the candidate will complete training in the following areas: 1)
interdisciplinary education research methods (qualitative and quantitative); 2) advanced
statistical analyses, research design/methods, & responsible conduct of research; 3) leadership
and project management training; 4) grant and manuscript writing; and 5) training in program
evaluation and administration. This will advance the aims of the SCISIPBIO study to allow for
the examination of additional factors that may impact trainee mental health outcomes and to
expand the investigation of mentor-mentee-match to examine outcomes across national data,
while advancing the career trajectory of an outstanding future scholar in biomedical workforce
development, education, and training.

Public health relevance
NARRATIVE: The success of the US biomedical research enterprise depends on effective education and training of future biomedical workforce employees and leaders. The impact of training environment support for professional development, mental health and well-being, and mentor- mentee match impact not only individual career outcomes of graduate and postdoctoral trainees but also the development of the biomedical workforce more broadly. We aim to catalyze evidence-based policy change institutionally, locally and nationally, to drive development of the biomedical workforce.